Consumer Assessment of Healthcare Providers and Systems (CAHPS) VI

Summary/Abstract
This application proposes a program of research, development, and evaluation of the use
of consumers’ assessments of health care for informing health care choices and quality
improvement. The goals of the program are organized in five areas: (1) Survey and
supplemental item set development, revision of surveys, and trademarking; (2) Survey
methods research aimed at achieving equity in patients’ experience of care; (3) Analysis
and reporting of patient experience data, including assessments of how well different
subgroups in the population are represented in survey responses; (4) Patient experience
quality improvement studies based on CAHPS data; and (5) Developing internal and
external program communication strategies to critical stakeholders.
The proposed methods include focus groups, cognitive interviewing, interviewing of
expert informants, establishing technical expert panels with nationally recognized
experts, and field tests of draft surveys. The team will use standard psychometric
statistical techniques to analyze survey data. The team will conduct experiments to
assess reporting strategies and quality improve initiatives.
The applicants are a consortium of experts in consumer survey design, report
development, experimental assessment of consumer perceptions and medical care choice
behavior, patient experience quality improvement, evaluation research, and
communication and dissemination from the Yale School of Public Health, Mass General
Brigham healthcare system and Harvard Medical School, the Center for Survey Research
at the University of Massachusetts, the University of Pennsylvania, Columbia University,
and several nationally known independent researchers and consultants. This consortium
proposes maintaining continuity in the CAHPS development process by continuing
critical activities and well-established collaborations from previous CAHPS projects and
Centers for Medicare & Medicaid Services (CMS) projects, while strengthening the team
to bring new skills, perspectives, and expertise to the project. The team has close
partnerships with collaborating demonstration sites and has established relationships with
public and private organizations that share an interest in refining and assessing CAHPS
products for improved consumer decision making and quality improvement.

Public health relevance
Project Narrative The CAHPS VI team will develop, test, and maintain CAHPS surveys; survey methods and protocols; and analysis programs. In addition, the team will conduct and evaluate quality improvement projects. The study results, surveys, reporting materials, and quality improvement methods will be communicated and promoted to improve patients’ care experiences.